Creating an improved oncolytic virus through directed evolution and virus-driven expression of a cancer-targeting peptid

Project Summary/Abstract. The current treatment regimen for glioblastoma, surgical resection followed by
radiation and chemotherapy, increases median survival from 12.1 to only 14.6 months. Generating effective
therapies against glioblastoma is difficult because treatments must: 1) gain access to the brain and target
tumor cells without damaging healthy cells, 2) target spread out cells since glioblastoma is not contained
within a defined mass like other cancers, and 3) trigger the host’s immune response to overcome immune
suppression mediated by glioblastoma cells, including highly invasive and resistant glioblastoma stem cells
(GSCs). Neurotropic oncolytic viruses (NOVs) are a promising treatment option since they cross the BBB and
preferentially target rapidly dividing cancer cells throughout the brain while stimulating host immune
responses to target the tumor. OVs can also be engineered to produce foreign proteins to augment the
vector’s killing capacity. Thus, NOVs overcome many of the limitations of other glioblastoma treatment
options. Semliki Forest virus (SFV) is a potent and safe NOV, but there are limitations in its effectiveness
since some glioblastoma cells are refractory to SFV infection, resulting in incomplete tumor removal. Our
long-term objective is to create virus-based therapies that reduce human disease burden. This proposal
aims to enhance SFV’s therapeutic efficacy against glioblastoma using directed evolution and virus-mediated
delivery of a potent anti-GSC peptide. Our preliminary data show that we can effectively adapt a virus to a
new environment using directed evolution, and we have also created highly safe vaccine candidates that
express cytokines. Finally, we have developed a highly effective GSC-targeting peptide, generated SFV
expressing the peptide, and showed it has more potent killing activity against glioblastoma cells while being
safe in healthy cells. We hypothesize that more potent, yet still safe, oncolytic SFV vectors can be generated
using directed evolution and virus-driven expression of cancer-targeting peptides. We will test our hypothesis
using rigorous molecular virology, ex vivo, and in vivo methods and a multidisciplinary team of experts in
virology, immunology, and oncology. In Aim 1, we will use directed evolution in 3D glioblastoma organoids to
select for a glioblastoma-adapted virus. The outcome of this aim will be a glioblastoma-adapted virus, which
we expect will improve disease outcomes and have minimal adverse effects. In Aim 2, we will test SFV-
expressing a potent GSC-targeting peptide in relevant in vivo and ex vivo models. The outcome of this aim
will be a virus targeting GSCs and differentiated glioblastoma cells. Impact: These studies will develop two
novel strategies to create more potent OVs. Completing these high-risk, high-reward studies will lay the
groundwork for studies aimed at clinical testing of NOVs to treat all types of cancer in humans and will launch
an exciting research direction in the lab of a productive young investigator with a drive to improve cancer
treatment outcomes.

Public health relevance
Project Narrative. The current treatment for glioblastoma, surgical removal followed by radiation and chemotherapy, increases median survival from 12.1 to only 14.6 months. Neurotropic oncolytic viruses (NOVs) are a promising treatment option since they enter the brain, preferentially target rapidly dividing cancer cells, stimulate the host immune responses to target the tumor, and can be engineered to produce foreign proteins to augment the vector’s killing capacity. Here, we will develop more potent and safer NOVs using two novel strategies: (1) an evolution-based approach to adapt the virus to the tumor to make it more effective and (2) a virus that produces a molecule that kills cancer stem cells.